The Role of Kaiso as a predictive breast cancer biomarker in Africa and across the African Diaspora

Around the world, women of African ancestry and throughout the African Diaspora, show at significantly higher rate of mortality compared to other populations. Several recent studies have suggested a prominent role for tumor biology. Implicated causal factors include i) higher frequencies of aggressive breast cancer subtypes ii) more aggressive biological behavior of low-risk breast cancers, and iii) decreased predictive accuracy of prognostic gene signatures associated with genetic ancestry. Recently we have shown the subcellular localization of the breast cancer biomarker Kaiso (ZBTB33) in both the nucleus and cytoplasm of breast cancer cells were each more associated with biologically aggressive cancers and independent predictors of poor breast cancer survival and response to neoadjuvant therapy, revealing that cytoplasmic Kaiso was highly correlated with an “immune-evasive” or “immune-suppressed” tumor microenvironment. Mechanistically cytoplasmic Kaiso was shown to be very highly correlated with the machinery involved in extracellular vesicle (EV) loading and secretion, a process known to have a dramatic influence on the micro-environment of the tumor bed and metastatic niche. In this study, we will validate and extend these observations of the subcellular localization of Kaiso as an independent predictive biomarker of breast cancer survival and the tumor micro-environment using two breast cancer cohorts from Africa and across the African diaspora. One from the Columbia University Herbert Irving Comprehensive Cancer Center (N=487) and the other from the Aga Khan University Hospital, Nairobi, Kenya (N=237) (Specific Aim 1). Using a multi-omic approach that will integrate the analysis of tissue microarrays (TMAs), quantitative multiplex immunofluorescence (qMIF), gene expression (RNA-seq), tumor mutational signatures and frequency (whole-exome sequencing), deep annotation of patient clinicopathological features, environmental exposures, and genetic ancestry, we will define prognostic models that will demonstrate the role of Kaiso in predicting breast cancer survival, response to therapy and the role of genetic ancestry in breast cancer evolution and outcome (Specific Aim 1). We will also define how Kaiso modulates the influence of EV secretion on breast cancer growth, invasion, metastasis, and immune evasion in murine xenograft models using cells engineered for depleted or enhanced Kaiso expression (Specific Aim 2). These goals will be accomplished through a unique collaboration involving a highly-specialized multi-disciplinary team of breast cancer pathologists, tumor biologists, molecular biologists, biostatisticians, bioinformaticians, epidemiologists, and genome researchers.

Public health relevance
In a rural breast cancer cohort from the South Eastern United States, the levels of the breast cancer biomarker, Kaiso in the cytoplasm, and the nucleus of breast cancer cells are each independent predictors of breast cancer survival. Surprisingly, the cytoplasmic Kaiso levels were also predictive of an immune exhausted or immune-suppressed tumor microenvironment. In this study we propose to validate these observations using 2 different breast cancer cohorts from Africa and across the African diaspora; show how these predictive linkages are influenced by patient features, genetic ancestry and exposures, tumor gene expression, tumor patterns of somatic mutation, and tumor mutational signature; and elucidate the mechanisms linking Kaiso with the breast cancer tumor microenvironment